Platform technology for targeted delivery of proteins to the intestines

Project Summary/Abstract
Inflammatory bowel diseases (IBD) affect over 1.5M people in the US and despite the wide array of treatment options for
maintaining remission in ulcerative colitis (UC), significant risks of infection and malignancy accompany otherwise
effective biological agents. Locally-delivered small molecule therapies, such as second-generation glucocorticoids
exemplify the unique advantage of targeted delivery to improve therapeutic efficacy while reducing systemic toxicity in
UC. Many biologics that are used for treatment of IBD (e.g., anti-TNFα therapies), enable pleiotropic responses in the
gastrointestinal (GI) tract to induce and maintain remission in IBD patients; however, these biologics necessitate systemic
delivery as opposed to local delivery and remain costly with rising estimates of $50,000 – $150,000 in drug acquisition
costs per year. In addition to the desire for affordable therapies, there is an urgent need for technologies that improve local
targeting of biologics to the large intestine due to higher efficacy, less off-target effects, and a substantial reduction in
drug required to achieve an effect.
Specific technical challenges remain which have prevented implementation of intestine-targeted oral delivery systems for
biologics including: (1) inactivation of biologics by enzymes, stomach acids, bile, digestive process, etc., (2) shelf-
stability of biologics in oral dosage forms, (3) lack of spatial access to discrete sites of inflammation upon release in the
intestines, and (4) consistent and reliable delivery at the target site. To address these challenges, we have recently
developed platform delivery systems for dietary proteins as well as sensitive biologics that are capable of sustained release
over a 24-hour period in physiological situations, enabling protection against harsh conditions in the GI tract, and
compatible with a variety of proteins tested to date. This proposal aims to expand this platform to protect therapeutic
proteins (biologics) so as to enable their targeted oral delivery to the intestines. Our initial investigation will focus on
rhPRG4, a large protein involved in epithelial lubrication, towards treating the symptoms of UC. Specifically, we aim to
formulate rhPRG4 to protect against bile salts, enzymes, acids, moisture, and light with a targeted delivery to the colon.
Furthermore, we will assess viability of released rhPRG4 to reduce cytokine production in an in vitro model of
inflammation

Public health relevance
Project Narrative This proposal involves the optimization of a targeted intestinal release platform for precision delivery of large biologics including proteins. Targeted intestinal delivery system for biologics as a whole class, are anticipated to broadly improve safety profiles, improve patient compliance for oral dosage forms rather than infusions or injections, reduce pharmaceutical waste, and even offer treatment of chronic diseases at their source. Development of an effective orally- administered local delivery system for gastrointestinal biologics would yield an estimated $4 billion dollars per year in savings over cumulative drug costs, lowered incidences of serious adverse events/hospital stays, and reduced pharmaceutical waste.